Clarifying proximal mechanisms linking interpersonal stressors to suicidal behavior in youth: A multi-informant real-time monitoring study

PROJECT SUMMARY
Suicide is the 2nd leading cause of death among adolescents, and, alarmingly, rates have continued to
increase over the past decade. With the current dearth of empirically supported psychosocial interventions for
adolescent suicidal behavior, there is a great need to identify processes underlying risk for this outcome.
Interpersonal negative life events (NLEs) have been linked to short-term risk for suicidal behavior (i.e., suicide
attempts and deaths). However, how or why these interpersonal NLEs confer risk is currently unclear.
Understanding the moderators and mechanisms of the link between interpersonal NLEs and suicidal behavior
is crucial in order to identify when adolescents are most at risk and to develop interventions that can target
these mechanisms and reduce suicidal behavior during these periods of risk. Interpersonal NLEs may lead to
suicidal behavior through their impact negative emotional states (e.g., agitation) and social connectedness,
and further magnified by rejection sensitivity, emotion regulation difficulties, and sleep disturbance. Although
past studies have found these constructs to be linked with suicidal behavior, this research is limited in three
key ways: (1) Most prior studies have examined long time periods (months and years), which lack the temporal
resolution to examine these mechanisms on the time scale in which they unfold (hours and days). We will
intensively (over hours and days) examine how interpersonal NLEs relate to suicidal behavior. (2) Little is
known about the impact of the social system, such as the family unit, and what key collaterals (e.g., parents)
are observing in the short-term leading up to their adolescent’s suicidal behavior. By including parental reports,
this study will reveal parents’ awareness of their adolescents’ suicide risk and potentially identify how parents
can help them during these high-risk times. (3) Most past work has been insufficiently powered to examine
links with suicidal behavior (instead focusing on suicidal thoughts). We propose to examine how and why
interpersonal NLEs confer risk for suicidal behavior using smartphone-based ecological momentary
assessment (EMA) and wearable sensors (i.e., wrist actigraphy) among 600 adolescents and their parents
recruited from three diverse sites (Brown, Old Dominion, Rutgers) during the month after discharge from acute
psychiatric care. We will address three aims: Aim 1. Examine how interpersonal (particularly familial and peer)
NLEs increase risk for suicidal behavior through increased negative emotion and decreased social
connectedness. Aim 2. Examine how rejection sensitivity moderates the link from interpersonal NLEs to
negative emotionality/decreased social connectedness. Aim 3. Examine how sleep disturbance and emotion
regulation difficulties moderate links from increased negative emotions and decreased social connectedness to
suicidal behavior. This work will significantly advance understanding of proximal risk for suicidal behavior in
youth and how the field assesses and treats suicidal adolescents.

Public health relevance
PROJECT NARRATIVE Suicide is the 2nd leading cause of death among adolescents. Interpersonal negative life events (NLEs) have been consistently linked to short-term risk for suicidal behavior, but it is currently unclear how or why these events confer risk. The current study will examine the moderators and mechanisms linking interpersonal NLEs to suicidal behavior using an intensive real-time monitoring (smartphone ecological momentary assessment + wearable actigraphy) design with a large sample of 600 adolescents and their parents, after discharge from acute psychiatric care from three diverse sites (Brown, Old Dominion, Rutgers) recruited and followed for a month.